A novel cellular identity regulatory pathway that drives anokis resistance-mediated TNBC growth and metastasis

Women in the United States have a 1 in 8
PROJECT SUMMARY
lifetime risk of developing breast cancer. Among the various breast
cancer subtypes, triple-negative breast cancer (TNBC) carries the worst prognosis and only 11% TNBC patients
with distal metastasis are expected to survive beyond 5 years. Furthermore, current therapies for TNBC also
provide marginal and in most cases only short-term clinical benefits. Therefore, novel and more efficacious drugs
for TNBC treatment are in urgent need. Most epithelial cells are dependent upon contacts with the extracellular
matrix (ECM) for survival and undergo apoptosis when they lose contact with the ECM, a process termed anoikis.
However, tumor cells, upon detachment from the ECM, are capable of evading anoikis. The acquisition of anoikis
resistance is a critical step that contributes prominently to TNBC tumor growth and metastasis. Thus, anoikis
inducers represent valuable therapeutic targets for TNBC treatment. However, the molecular drivers of anoikis
resistance that can be therapeutically targeted in TNBC remain largely unknown. Protein kinases are excellent
drug targets with over 25 drugs targeting kinases are approved by US FDA for treating a wide-variety of cancers
in clinic. Therefore, to identify kinases that confer anoikis resistance in TNBC cells, we performed a kinome-wide
shRNA screen and identified the PDZ Binding Kinase (PBK) as a driver of anoikis resistance in TNBC cells. We
found that PBK was overexpressed in TNBC and predicted poor prognosis. Furthermore, genetic or
pharmacological inhibition of PBK induced anoikis in TNBC cells. Based on these results, we hypothesize that
PBK confers anoikis resistance to drive TNBC tumor growth and metastasis. The overall objective is to determine
the in vivo role of PBK in TNBC tumor growth and metastasis and evaluate pharmacological targeting of PBK for
TNBC therapy. Aim 1 studies will determine the in vivo role of PBK as a driver of TNBC tumor growth and
metastasis. First, using mammary fat-pad injection-based orthotopic mouse model of TNBC tumor growth and
metastasis we will determine if genetic inhibition of PBK suppresses TNBC tumor growth and metastasis. We
will also measure circulating tumor cell (CTC) load in vivo in this mouse model to monitor the effect of PBK
inhibition on anoikis induction in vivo. Next, based on our preliminary results, we will test the role of PBK-
dependent phosphorylation of transcription factor TWIST1 in reprogramming TNBC cells to acquire
mesenchymal cell state and thereby acquiring anoikis resistance. Aim 2 studies will ascertain the efficacy of PBK
inhibitor in vivo for TNBC treatment. To do so, we will determine if a highly-potent and efficacious PBK inhibitor,
OTS-964 can effectively suppress TNBC tumor growth and metastasis utilizing established TNBC cell lines, and
patient-derived xenografts (PDXs)-based models. Taken together, our findings will have strong scientific impact
by establishing a novel role of PBK in driving cell state regulatory pathway that facilitate TNBC tumor growth and
metastasis as well as by establishing PBK targeting as an effective approach for treating TNBC.

Public health relevance
PUBLIC HEALTH SIGNIFICANCE Triple negative breast cancer (TNBC) is a highly metastatic subtype of breast cancer with low survival rate and limited therapeutic options and therefore, novel and effective therapies are urgently needed for TNBC treatment. We discovered that PBK kinase is a driver of anoikis resistance, a cell state that promotes TNBC tumor growth and metastasis, and thus, the studies in this proposal aim to establish PBK as a driver of TNBC tumor growth and metastasis, and establish small-molecule inhibitor of PBK kinase as novel and efficacious therapeutic agents for TNBC treatment.